Hedgehog Signaling in Development and Metabolism

Abstract:
Hedgehog (Hh) signaling controls growth and patterning during embryonic development and homeostasis in
adult tissues. Dysregulation of Hh signaling is implicted in many human disorders, including several types of
cancer. Hh binding to the 12-transmembrane protein Patched (Ptc) elicits intracellular signaling by relieving
Ptc-mediated inhibition of the 7-transmembrane protein Smoothened (Smo). Despite significant progress, key
questions persist regarding the mechanisms by which Ptc inhibits Smo in the absence of Hh and how Hh
stimulation alleviates this inhibition. In the past years, this team has generated new insights into Hh signaling
mechanisms, including: 1) Smo phosphorylation by multiple kinases, which leads to Smo cell surface
accumulation and signaling activity; 2) Smo sumoylation induced by Hh, which activates Smo; 3) Smo
ubiquitination that downregulates Smo cell surface accumulation and promotes Smo endocytosis; and 4) Smo
activation by Phosphatidyl-inositol 4-phosphate (PI(4)P) and phosphatidic acid (PA) through direct interaction
with Smo C-tail and transmembrane helixes, respectively. The goal of this research program is to understand
how Hh signals are sensed and transmitted to control downstream biological events that ultimately govern cell
growth and patterning. Proposed studies use a combination of genetic and biochemical approaches to build on
prior contributions and to transition to newly emergent avenues of inquiry. The knowledge gained from the
proposed studies will provide novel insights into mechanisms surrounding Smo suppression by Ptc and
activation by cholesterol, PI(4)P, and PA. In addition, expected outcomes will provide novel insights into human
developmental disorders and adult neurodegenerative diseases and will promote development of diagnostic
tools and novel therapeutic approaches to transform current concepts of Hh signaling in cancer and
neurodegenerative diseases.

Public health relevance
PUBLIC HEALTH RELEVANCE Hedgehog (Hh) signaling is known for its role in directing processes such as cell growth, proliferation, and differentiation during embryogenesis. Mutations in Smoothened (Smo), a critical protein in the signal reception system, results in human diseases such as basal cell carcinoma and medulloblastoma. Investigation of how Ptc inhibits Smo in the absence of Hh and how Hh stimulation alleviates this inhibition will provide insights into developmental problems and create novel concepts of Hh signaling in cancer and neurodegenerative diseases.